Designing better T cell epitopes for improved T cell vaccines and therapies

Abstract
The most important feature of antigenic peptides that stimulate potent T cell responses during vaccination
or adoptive T cell therapies is their ability to bind and stabilize Major Histocompatibility Complex (MHC) mole-
cules. Decreasing T cell receptor (TCR) signaling in response to cognate epitope/MHC programs functionally
distinct pools of memory CD8+ T cells. This proposal builds on the very unexpected finding that specific sets of
T cell epitopes promote the induction of functionally superior memory CD8+ T cells exhibiting higher fitness and
stem cell-like properties. Memory T cells with stem cell-like features maintain greater progeny potential, have
higher self-renewal, survival and clonal expansion capacities. They are considered at the apex of memory cells
and the most ideal subset of memory CD8+ T cells for effective responses against tumors and chronic infec-
tions. In this proposal, we hypothesize that the mode of TCR interaction with its cognate antigenic peptide de-
termines the fate of naïve T cells during priming. We will use molecular dynamic simulation coupled to func-
tional in vitro and in vivo assays to define and validate the key molecular and TCR/epitope interacting features
that promote the differentiation of stem-cell like memory CD8+ T cells. We propose to develop an algorithm for
the identification and design of such T stem-cell skewing epitopes. Overall, the work will provide an innovative
framework on how to best design antigenic peptides that favor the acquisition of stem cell-like properties by
memory T cells. The project has the potential to directly impact the longevity and functional efficacy of i) vac-
cine-induced memory T cells, and ii) adoptively transferred T cells (both Chimeric Antigen Receptor (CAR) and
non-CAR) in the context of life-threatening chronic infections and cancers.

Public health relevance
Public Health relevant statement This project is to understand how to make better T cell vaccines, and improve adoptive T cell therapies. The proposal focuses on populations of white blood cells (leukocytes) that are involved in protecting individuals against intracellular microbial pathogen infections and tumors. These cells are cytotoxic (CD8+) lymphocytes, they can be induced upon vaccination and are long-lived, therefore are defined as 'memory' lymphocytes. They can express multiple functions that are important to help the host fighting against infectious microbes and tumors. We discovered that the protective effectiveness of these memory cells depends on what they exactly recognize early on during vaccination. We propose to understand the details of the recognition process using computational modeling approaches and validating them in vivo. A major outcome of our work is to help better rational design of immunization cocktails to improve vaccines and T cell therapies.